Georgia Department of Agriculture's Implementation of the Animal Feed Regulatory Program Standards (AFRPS)

Project Summary: The Animal Feed Regulatory Program Standards (AFRPS) establish a uniform foundation for the design and management of State programs responsible for the regulation of animal feed. It is composed of eleven standards that serve as an objective framework to evaluate and improve components of participating states’ feed programs. With the implementation of these standards, Georgia’s feed program will be able to achieve and maintain programmatic improvements that help ensure the safety and integrity of the U.S. animal feed supply. The program standards include a state’s feed program’s regulatory foundation, training, inspection program, auditing, feed-related illness or death and emergency response, enforcement program, outreach activities, budget and planning, laboratory services, sampling program, and assessment and improvement of standard implementation. Georgia’s voluntary implementation of the Animal Feed Regulatory Program Standards (AFRPS) in cooperation with other states and the FDA ensures a uniform and consistent approach to feed regulation among jurisdictions, including the sharing of information and the coordination of resources.

Public health relevance
Project Narrative: The mission of the Georgia Department of Agriculture (GDA) is to protect consumers, promote agriculture both locally and globally and assist our customers using education, technology and a professional workforce. The GDA will voluntarily use the Animal Feed Regulatory Program Standards (AFRPS) as the foundation for the design and management of the State’s animal feed regulatory program. As part of a national effort among states and the FDA, the State feed programs implementing AFRPS will be able to achieve and maintain programmatic improvements to ensure the safety and integrity of the US animal feed supply. The State’s implementation of the AFRPS will ensure Georgia is part of a uniform and consistent approach to feed regulation across the US, including the sharing of information and the coordination of resources.